Investigating the molecular mechanisms of Plasmodium vivax invasion in Duffy-negative hosts

ABSTRACT
While there have been significant gains in malaria control, mainly focusing on Plasmodium
falciparum (Pf), Plasmodium vivax (Pv) has been expanding to fix the niche left behind. This
phenomenon could be due to the formation of dormant liver forms, called hypnozites,
sequestration in extravascular spaces, and early mosquito transmission of sexual staged
parasites. Pv was thought to be absent from Africa due to the high prevalence of Duffy-
negativity, an antigen on human erythrocytes that was thought to be required for Pv infection.
There has been a paradigm shift in this belief due to multiple reports of Duffy-negative invasion
throughout the African continent. Despite these reports, there has not been a definitive invasion
pathway identified for Pv that facilitates Duffy-negative invasion. This proposal aims to support a
promising MD/PhD student's career development and scientifically help us understand the
mechanisms that govern Pv Duffy negative invasion through a dual in vitro and in vivo
approach, utilizing cutting edge genomics and computational tools to understand the molecular
mechanisms of Duffy-negative invasion at the single cell level. By investigating Pv invasion
utilizing an in vitro model inhibited by invasion blocking monoclonal antibodies, a novel line of
Plasmodium knowlesi that can invade Duffy-negative erythrocytes, and single cell RNA
sequencing (scRNAseq) (Aim 1), we will identify invasion pathways that are upregulated to
facilitate alternative invasion pathways at the level of the malaria cell cycle stage. We will
validate these pathways through isolating Pv samples from an ongoing study in Duffy-positive
and Duffy-negative individuals (Aim 2). This work will provide key insights into Pv pathogenesis
that will inform malaria control strategies and public health interventions globally. In addition to
the scientific training the trainee will gain, he has organized a group of scientific and clinical
mentors that will guide his professional development to become a unique clinical scientist at the
intersection of infectious disease and maternal health. His training in bioinformatics, clinical
practice, and global health research will allow for gains in the understanding of the immense
clinical burden of infectious disease in pregnancy, specifically malaria in pregnancy, and a
foundational education in his career as a physician scientist.

Public health relevance
PROJECT NARRATIVE The realization of Plasmodium vivax's ability to invade red blood cells of Duffy negative individuals and occurring commonly in Africa changed the paradigm of our understanding of Plasmodium vivax biology. However, the underlying mechanisms of this phenomenon are yet to be understood. This proposal will provide career development, through didactic and mentored training, for a promising MD/PhD student to investigate potential mechanisms using a combined in vitro and in vivo approach that leverages advanced genomic and bioinformatic techniques.